Increasing Recognition of Acute Kidney Injury among Hospitalized Pediatric Patients

Proposal Summary
Acute kidney injury (AKI) affects up to 33% of hospitalized pediatric patients within the United States. Patients
with hospitalizations complicated by AKI have an increased mortality rate of 15.3%. AKI is associated with
adverse short-term outcomes such as increased length of hospital stays and increased mortality among adult
and pediatric populations. Additionally, pediatric patients who develop AKI are at a high risk for developing
chronic kidney disease (CKD). The etiology of AKI is multifactorial as demographic information, disease, illness
severity, nephrotoxic medication (NTMx) administration, and therapeutic factors all increase a patient’s risk of
developing AKI. Currently, there is no existing prediction model available to identify non-critically ill patients risk
of AKI development. Early recognition of AKI will decrease adverse events such as the development of CKD,
prolonged hospitalizations, and will ultimately promote the improved quality of life for these patients. Therefore,
the purpose of this study is to develop a clinical prediction model to estimate the risk of AKI development among
non-critically ill hospitalized pediatric patients. The specific aims of the proposed project are to: 1. Develop and
validate a clinical prediction model at the point of admission for AKI among non-critically ill hospitalized pediatric
patients, that closes the gap between actual and NINJA identified AKI. The potential predictors in the model
include comorbidities, sex, age, race, height, weight, prior hospitalizations, and serum creatinine. Predictors will
be selected to maximize the sensitivity and specificity of the prediction model, 2. Determine if inpatient factors
during the hospitalization, such as fluid balance and nephrotoxic medication administration, enhance the
prediction model. The NINJA database was established in 2016 and monitors for NTMx administration among
hospitalized pediatric patients using variables from the EHR. It has the ability to capture when a patient has
developed AKI or is at risk for developing AKI based on the NTMx they are receiving. The risk factors of AKI
listed in Aim 1 will inform the development of the prediction model. Then, inpatient factors during a hospitalization
will be incorporated to further enhance the prediction model. This innovative work holds significant promise to
improve renal outcomes in children, a goal that is perfectly aligned with the strategic priority of NIDDK to prevent
the development and halt the progression of kidney disease. This provides an exceptional training opportunity
to the applicant to develop the analytic skills to develop a prediction model using regression modeling.

Public health relevance
Project Narrative The prevalence of acute kidney injury (AKI) in the United States continues to rise despite ongoing efforts to combat its occurrence. As a risk factor for chronic kidney disease, increased length of hospital stays, and increased morbidity and mortality, it is imperative to determine new strategies and engage bedside providers in the early recognition of AKI. This proposed dissertation study will develop and validate a clinical prediction model to increase early recognition of AKI among hospitalized pediatric patients ages 0-18.